Discovery of the mechanisms governing Natural Killer T-cell activation and therapeutic potential in cancer

Abstract
While immunotherapies have revolutionized the treatment of cancer over the past 15 years, many patients
still do not respond to these treatments, leaving a sizeable therapeutic need unmet. Recently, several studies
have focused on an understudied class of lipid antigen responsive T cells, called Natural Killer T-cell (NKT), to
improve immunotherapy response rates. NKT cells recognize lipid antigens presented on the receptor CD1d via
their T cell receptor and help support anti-tumor immune responses by producing cytokines and killing
immunosuppressive myeloid cells and CD1d+ tumor cells. NKT cells effectively infiltrate tumors and correlate
with good prognosis in many types of human cancer; however, how they are recruited to tumors, what tumor
specific lipid antigens they recognize, and mechanisms of immune evasion are entirely unknown. These three
unanswered questions represent a gap in our understanding of NKT cell biology that has become increasingly
important to fill as NKT cell therapies continue to show promise. In the F99 phase of this proposal, I will address
the question of how NKT cells are recruited to tumors and whether increasing NKT cell trafficking to tumors could
enhance the efficacy of current generation NKT cell therapies. Leveraging the unique tumor model system I
developed in our lab, where deletion of the mitochondrial gene Ndufs4 induces NKT cell accumulation in
melanoma tumors, I will: 1) Define the mechanism of NKT cell recruitment to Ndufs4 deleted tumors by adoptively
transferring labeled NKT cells into tumor bearing mice; 2) Determine the metabolic pathways and components
necessary for NKT cell recruitment to Ndufs4 deleted tumors by co-culturing NKT cells with tumor cells treated
with a panel of siRNAs; and 3) Determine the synergy between Ndufs4 deletion and NKT cell therapies by
treating tumor bearing mice with chimeric antigen receptor (CAR) expressing NKT cells. This aim will support
my hypothesis that altered mitochondrial metabolism in Ndufs4 deleted cells drives increased trafficking of NKT
cells to tumors and this increased trafficking will improve the efficacy of current generation CAR-NKT cell
therapies. In the K00 phase of this proposal, I will work under an expert in CD1 biology and lipid ligand
identification to address the questions of how epithelial cancers evade NKT cell surveillance by downregulating
CD1d and identify lipid tumor specific antigen (TSAs) and the structural basis of their recognition by NKT cells
by: 1) Determining the regulators of CD1d using a genome-wide CRISPR screen; 2) Identify CD1d TSAs in
prostate cancer and their therapeutic utility using a CD1d purification methodology developed by my K00
sponsor; and 3) Define the structural basis of CD1d TSA recognition of NKT cells using X-ray crystallography.
This aim will support my hypothesis that epigenetic changes drive CD1d repression in epithelial cancers and that
NKT cells can recognize CD1d bound TSAs to promote anti-tumor immunity. Altogether, this proposal will
significantly advance our knowledge of NKT cell behavior and potential therapeutic benefits in cancer.

Public health relevance
Project Narrative Immunotherapies have revolutionized the treatment of many cancers; however, many cancers do not respond to these treatments or become resistant over time. Natural Killer T (NKT) cells are a poorly understood T cell subset whose activity may help to solve resistance in some current immunotherapies. This research proposal will investigate the molecular mechanisms governing NKT cell recruitment to cancers, activation by tumor specific antigens, and strategies to improve current NKT cell therapy response rates.